Role of Daxx in Reovirus-induced Neuronal Apoptosis

DESCRIPTION (provided by applicant): Neuronal apoptosis is a common pathological feature in neurological disorders of diverse etiology. Viral encephalitis, an exemplary disease associated with neuronal apoptosis, remains a significant cause of morbidity and mortality due to severely limited diagnostic and treatment options. The primary goal of the proposed research is to utilize in vivo, ex vivo, and in vitro models of reovirus infection to characterize signaling pathways activated during neuronal viral infection and, ultimately, to identify novel therapeutic targets for neuroprotection. Fas death receptor signaling and c-Jun N-terminal Kinase (JNK) activation are known to contribute to reovirus-induced neuronal apoptosis. These seemingly isolated findings are consolidated into a broader model, described in this proposal. As discovered in various non-viral models of apoptosis, Fas signaling originating at the cell membrane may initiate intracellular JNK activation by proceeding through the Fas-Daxx-ASK1-Sek1-JNK apoptotic pathway. I hypothesize that Daxx is an especially important mediator of apoptosis in the context of viral infection because its expression is controlled by the host anti-viral immune response. In Aim 1, models of dominant-negative Daxx overexpression (in vivo and in vitro) and siRNA- mediated Daxx knockdown (in vitro only) will be utilized to determine the relative importance of Daxx in reovirus-induced apoptosis and neuropathogenesis. Aim 2 will employ immunofluorescence imaging and Western blotting techniques to assess the binding interactions and signaling roles of Daxx following reovirus infection. Finally, Aim 3 will address the possibility that Daxx expression is regulated by interferon (IFN) released by the virally infected host. Overall, I hypothesize that IFN signaling and consequential Daxx gene expression leaves virally infected neurons vulnerable to apoptosis. The proposed studies will probe the interfaces between viral infection, immunity, and cellular/tissue/host death to deepen our understanding of the viral-host interaction and neuronal apoptotic signaling. Furthermore, these studies will potentially build the theoretic basis for the eventual development of neuroprotective pharmaceuticals.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neuron death may occur in patients suffering from some types of brain disease. We expect that the protein, Daxx, may play a role in causing death of virus-infected neurons. Understanding how Daxx may contribute to anti-viral immunity and neuron death may lead to the development of new therapies for devastating brain diseases, such as encephalitis. PROJECT NARRATIVE Neuron death may occur in patients suffering from some types of brain disease. We expect that the protein, Daxx, may play a role in causing death of virus-infected neurons. Understanding how Daxx may contribute to anti-viral immunity and neuron death may lead to the development of new therapies for devastating brain diseases, such as encephalitis. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Neuronal death is a pathological feature of many neurological diseases; yet, the molecular mechanisms underlying this process remain elusive. Serotype 3 reovirus strains induce neuronal apoptosis, a form of programmed cell death, within the brains of neonatal mice and serve as a classic model for the study of lethal encephalitis. Previous work in our laboratory has demonstrated that Fas/FasL death receptor signaling and activation of the c-Jun N-terminal Kinase (JNK) contribute to reovirus-induced neuronal apoptosis (1-3). The connection between these two signaling pathways has not yet been demonstrated in any model of encephalitis, although studies conducted in other fields suggest that Daxx (Death Associated Protein 6) is the unifying link between membrane Fas signaling, intracellular JNK activation, and cellular apoptosis (4-6). I have recently shown that Daxx mRNA and protein is upregulated in the brains of reovirus-infected mice (7). Preliminary data suggests that this upregulation could be secondary to activation of the interferon (IFN) arm of the innate immune response. Newly synthesized Daxx protein localizes to the cytoplasm of infected neurons where it presumably interacts with Fas to propagate proapoptotic signals. In support of this, in vitro expression of a dominant-negative form of Daxx (DN-Daxx) inhibits reovirus-induced cell death. Overall, I hypothesize that expression of Daxx within the virally infected host is a component of the innate antiviral response; yet, contributes to neuronal apoptosis and brain injury. This proposal aims to utilize in vitro, ex vivo, and in vivo models of reovirus infection to characterize the role of Daxx in viral-induced apoptosis, with emphasis on how Daxx relates to normal and abnormal neurobiology. The results of the proposed studies will advance the understanding of how viruses induce neuronal death and will identify potential novel cellular targets for antiviral therapy and neuroprotection. Aim 1. Determine the extent to which Daxx contributes to virus-induced apoptosis and neuropathogenesis. My preliminary data suggest that reovirus-induced cell death is Daxx-dependent. I will utilize gene knockdown and protein overexpression methodology to investigate the potential proapoptotic role of Daxx following in vitro and in vivo reovirus infection. A. First, I will quantitatively measure virus-induced apoptosis (via Caspase 3 activation and Annexin-PI assays) in L929 fibroblast and neuronal-like PC12 cells, which have undergone siRNA-mediated Daxx knockdown (Daxx-KD) or stable transfection with wild-type Daxx (wtDaxx) or DN-Daxx. B. Next, I will compare reovirus-induced brain injury and neuronal apoptosis between trangenic DN-Daxx mice and wild-type (wt) littermate controls. C. In addition, I will determine whether DN-Daxx mice survive longer than wt littermates after reovirus challenge. Aim 2. Delineate whether Daxx links membrane Fas/FasL signaling to proapoptotic SAPK activation following viral infection. Stress Activated Protein Kinases (SAPKs) are a distinct family of Mitogen Activated Protein Kinases (MAPKs) known to play integral roles in the induction of apoptosis. Previous studies suggest that Daxx is an adaptor protein to Fas and an upstream mediator of SAPK signaling (4, 6, 8-10). Thus, increased cytoplasmic expression of Daxx within reovirus-infected neurons may promote Fas-Daxx binding and resultant transduction of proapoptotic signals to downstream molecules: Ask1 (MAP3K), Sek1 (MAPKK), JNK (SAPK), and p38 (SAPK) (see Figure 5). A. I will elucidate whether reovirus-induced Daxx directly binds upstream Fas and downstream Ask1 by employing dual-staining immunofluorescence and coimmunoprecipitation (Co-IP) techniques. B. I will next examine the signaling roles of neuronal Daxx and Ask1 following reovirus infection by accessing phosphorylation/activation status of downstream Sek1, p38, JNK, and c-Jun in wtDaxx, DN-Daxx, wtAsk1, and enzyme deficient K709R-Ask1 models. C. Finally, I will investigate the relative contribution of Daxx to Fas-induced apoptosis in the context of reovirus infection, by inhibiting Fas signaling with Fas soluble antibodies in infected brain slice cultures (BSCs) or PC12 cells expressing either wtDaxx or DN-Daxx. Aim 3. Define Daxx upregulation within the larger context of the host interferon (IFN) response against viral infection. My preliminary data reveal that Daxx is rapidly upregulated by IFN- treatment in vitro. This finding suggests that Daxx upregulation in the brains of reovirus-infected mice could be a consequence of the host immune response to viral infection as opposed to a direct result of viral infection. A. First, I will utilize recombinant IFN-B and anti-IFN-B antibodies to ascertain whether Daxx is indeed an interferon-stimulated gene and a potential mediator of the anti-viral response in the ex vivo and in vivo brain. B. To address whether IFN-induced Daxx upregulation occurs through the IFNR1-JAK-STAT transcriptional pathway, I will analyze Daxx expression in brain tissue of reovirus-infected IFNR1 -/- and STAT -/- mice. C. At last, I will determine if IFN-mediated upregulation of endogenous Daxx specifically heightens sensitivity to Fasinduced apoptosis by silencing IFN-induced Daxx expression with siRNA before inducing in vitro neuronal apoptosis with Fas-stimulating antibodies. Overall, this proposal seeks to elucidate the importance/function of neuronal Daxx and establish the rational for the therapeutic targeting of this molecule during CNS disease.